Administrative Core

ABSTRACT
The success of the UTEP Border Biomedical Research Center (BBRC) hinges on its Administrative Core (AC),
serving as the central hub for day-to-day operations and coordination of program projects and cores.
Committed to superior financial management, the AC also minimizes redundancy and leverages UTEP's
resources to provide an integrated infrastructure, while also promoting collaborations with other Research
Centers in Minority Institutions (RCMIs). The AC's mission includes leadership and oversight, involving the
coordination and supervision of proposed research, along with the integration of external and internal advisory
committees. Additionally, the AC provides administrative support for BBRC programmatic activities and
infrastructure, including faculty development, community engagement, and recruitment; and enhances growth
through mentoring and workshops within the biomedical research ecosystem. Responsible for overseeing the
U54 RCMI award and supplemental award funds, the AC ensures compliance with regulations and responsible
conduct of research. It also disseminates BBRC information and facilitates collaborations within UTEP as well
as the RCMI Coordinating Center (RCC). The AC monitors progress through external evaluators and the
utilization of appropriate metrics for cores, research projects, and advisory committees. In summary, the AC
manages the Center, and functions as a hub for interactions with UTEP’s administration, collaborators, the NIH
and other RCMIs. With seasoned leadership and effective strategies, the AC aims to support and enhance
institutional capacity in biomedical research, especially in areas related to Hispanic Health Disparities.